Interdisciplinary Biomedical Research Training Program

7. Project Summary
There continues to be a documented dire national need for veterinary specialists trained
in biomedical research. Furthermore, veterinary researchers play a key role in
multidisciplinary and interdisciplinary research activities since they naturally bridge basic
and clinical research. To address this training need, faculty in the North Carolina State
University College of Veterinary Medicine (CVM) established the Interdisciplinary
Biomedical Research Training Program (IBRTP) for veterinary students in 2009 with funds
committed to the program from the College of Veterinary Medicine and the T35 was first
funded in 2010. The objective of this training program is to provide interdisciplinary
biomedical research experience specifically targeted to veterinary students with a strong
interest in a research career. The training program also serves as a bridge to foster new
interdisciplinary research collaborations amongst faculty members. Trainees complete a
3-month research experience in the laboratories of faculty members drawn from nine
disciplines. Trainees are mentored by two faculty members from different disciplines to
create and execute an interdisciplinary project. The 33 faculty members participating in
this program are well funded and have a strong training track record. The ten disciplines
selected are areas of strength at NC State; Clinical Sciences, Cellular and Molecular
Biology, Neurosciences, Genetics and Genomics, Infectious Diseases, Statistics and
Epidemiology, Regenerative Medicine, Gastrointestinal Physiology, Computational
Biology, and Pharmacology and Toxicology. Research projects emphasize the melding of
two disciplines to create a novel approach to a biomedical research problem. Projects
combining clinical and basic science disciplines are given priority. Trainees will be
veterinary students in their first or second year who are building on prior research
experience. Four trainee slots were funded by the NIH in 2010. The number of NIH
supported trainee slots grew to 7 in 2012 and 10 in 2015. To date, a total of 59 NIH funded
trainees have completed the program. We propose in this renewal application that the
number of NIH funded training slots be maintained at 10 per year. Program requirements
include: 1) a weekly seminar series on topics related to research ethics and scientific and
professional development; 2) a weekly journal club discussing interdisciplinary research
papers; 3) participation in the Boehringer-Ingelheim-NIH National Veterinary Scholars
Symposium and the annual CVM Research Symposium.

Public health relevance
8. Narrative This Interdisciplinary Biomedical Research training program (IBRTP) addresses two critical national needs in biomedical research. First is the growing need for Veterinarians with training in biomedical research. Second is that more emphasis needs to be placed on translation of basic research advances to the clinical setting and this often requires an interdisciplinary approach.